UAB Blazer BRAIN (Broadening Representation And Inclusion in Neuroscience) Summer Program

We seek NINDS R25 funding for the Blazer BRAIN (Broadening Representation And Inclusion in Neuroscience)
Program at the University of Alabama at Birmingham (UAB). Although the number of U.S. citizens from
underrepresented minority (URM) groups earning doctoral degrees in science has increased over the past
decade, URMs continue to represent a small proportion of the scientists in the United States. Our UAB Blazer
BRAIN Program is a summer research experience that targets the obstacles impeding success with the goal of
increasing the number of trainees from diverse backgrounds in neuroscience research. We will recruit talented
undergraduates from our five partner HBCU institutions in AL, and nationally with a focus on the southeast
region. We aim to expose Blazer BRAIN undergraduate Scholars to research on the healthy nervous system
and neurological disease at UAB in laboratories of our federally funded faculty mentors. With continued
investment in Neuroscience at UAB by the School of Medicine and the Comprehensive Neuroscience Center,
the future of the Blazer BRAIN program is secure, and Scholars will benefit from the vibrant neuroscience
environment at UAB that currently exceeds $60M in NIH funding, with approximately $24M of that from NINDS.
The Blazer BRAIN Program will include career advising by the Program directors and research faculty mentors.
In addition, the Blazer BRAIN Program will partner with the NIH R25-funded UAB Roadmap Scholars (RMS)
Program, which also aims to promote diversity in neuroscience research but at the graduate level, by matching
Blazer BRAIN Scholars with RMS Aspirational Mentors (RAMs), to allow our Scholars to “see themselves” as
scientists in biomedical research careers. Blazer BRAIN Scholars will also be invited to attend the RMS NEURAL
conference, held every summer at UAB. Other value-added components of the Blazer BRAIN Program include
learning from their mentors about careers and work life balance as a neuroscientist at a major biomedical
research university; improvement of scientific communication skills; opportunities to present research at a
regional (UAB Summer Research EXPO) and national (ABRCMS, SACNAS or SfN) meeting; and assistance in
preparing applications for graduate school. Our primary goal for the initial funding period is to demonstrate
minimum 60% acceptance rate of Blazer BRAIN Scholars to PhD Programs. A rigorous evaluation plan is place
with metrics designed to achieve this success, with input to be received from Blazer BRAIN Scholars, mentors,
and internal and external advisory committees. If successful, the UAB Blazer BRAIN Program will increase
diversity in neuroscience research, and in turn promote the development of a richly diverse workforce in the
biomedical sciences.

Public health relevance
PROJECT NARRATIVE The UAB Blazer BRAIN (Broadening Representation And Inclusion in Neuroscience) Summer Program at the University of Alabama at Birmingham (UAB) focuses on increasing diversity in the neuroscience workforce through providing an outstanding summer research and educational experience for undergraduates earning their STEM degree at partner HBCUs and throughout the southeast U.S. This experience will instill confidence and excitement in these talented students and increase their desire for a career as a neuroscience researcher.